Non-Coding RNAs in Gene Regulation, Genome Defense, and Epigenetic Inheritance

PROJECT SUMMARY / ABSTRACT
Epigenetic systems regulate gene expression during reproduction and development and the misregulation of
these pathways leads to disease. Non-coding RNAs are major regulators and orchestrators of epigenetic
processes in all eukaryotes. For instance, non-coding RNA directs paramutation in plants, heterochromatin
formation in yeast, genome rearrangement in paramecium, and X-chromosome inactivation and imprinting in
mammals. Additionally, while most epigenetic information is erased each and every generation to ensure
totipotency of the germline, in some cases, epigenetic information escapes reprogramming and passes across
generations (termed transgenerational epigenetic inheritance or TEI). Current evidence suggests that non-
coding RNAs are major informational vectors for TEI in plants, worms, insects, and, possibly, mammals. The
long-term goal of my research program is to understand how non-coding RNA regulates and sculpts gene
expression programs and how this regulation is, in some cases, passed across generations.
We are using the metazoan model organism C. elegans to address these questions. To date our work
has identified a nuclear branch of the RNA interference (RNAi) pathway, which uses small interfering (si)RNAs
to regulate chromatin states and inhibit RNAP II elongation. We have also identified pathways and systems
required for transmission of epigenetic information across generations. Our recent studies have identified a new
type of membraneless organelle that houses proteins needed for TEI, identified two pathways that act as natural
breaks on TEI, and defined an underlying mechanism for TEI mediated by a new form of RNA modification that
we helped discover. And because we find that transposable elements are a major target of the C. elegans
epigenetic inheritance pathways, we theorize that one function of non-coding RNAs and TEI systems is to help
inoculate progeny against the expression of nucleic acid parasites.
Deregulation of epigenetic pathways contributes to the etiology of a number of human diseases. The
extensive links existing between non-coding RNA and epigenetic processes in all eukaryotes suggests that the
work we are doing in C. elegans will lead to insights that will be applicable to all animals and, therefore may help
us understand and treat disease in people.

Public health relevance
PROJECT NARRATIVE We are using the metazoan model organism C. elegans to explore how non-coding RNA sculpts gene expression programs, drives heritable epigenetic states, and directs antiviral and transposon defense. We rely heavily on forward genetic screens, which pragmatically cannot be done in most other systems, to help us understand these biological processes, about which little is known. We hope and expect that the work we do in C. elegans will provide a framework upon which others can build to develop novel treatments for disease in people.